Mechanisms of Pro-Resolving Mediators in Periodontal Regeneration

Dietary supplementation with the n-3 polyunsaturated fatty acids (PUFA) eicosapentaenoic acid (EPA) and
docosahexaenoic acid (DHA) for improving prevention or outcomes of inflammatory diseases, including
periodontitis, has been suggested and supported in the literature. However, there remains a critical need
to characterize their mechanism of action to optimize the use of nutritional supplements to benefit the
population. There are major gaps in knowledge as it pertains to the mechanisms by which EPA and DHA exert
their functional effects. Mechanistically, EPA and DHA supplements in the diet increase the concentration of
downstream hydroxylated-EPAs (HEPEs) including 18-HEPE, and hydroxylated-DHAs including 17-HDHA,
which are bioactive compounds. 18-HEPE and 17-HDHA are also the precursors for the immunoresolvents
known as E-series and D-series resolvins, respectively, which improve periodontal disease outcomes through
the activation of specific receptors on stem cells. There remain major gaps in our understanding of the
mechanistic relationship between stem cell dysfunction and periodontitis. Our data lead us to the hypothesis
that dietary supplementation with EPA and DHA, or their HEPE/HDHA metabolites, will have an impact on
treatment outcomes for periodontitis, in part, through the activation of the resolvin/stem cell receptor axis. We
will test the hypothesis using a combination of EPA/DHA- and HEPE/HDHA- based dietary supplements in our
pig model of stem cell enhanced periodontal regeneration measuring clinical outcomes and investigating
mechanism using cutting-edge mass spectrometry-based approaches and assessments of SPM receptor
expression and function. Overall, the proposed research will provide much needed clarity to the field of n-3
PUFAs and periodontal disease. The data will specifically provide a scientific rationale for future precision
clinical trials with dietary supplements for periodontitis treatment and prevention. The Central Hypothesis is
that dietary supplements containing EPA/DHA or HEPE/HDHA precursors of resolvins will enhance resolution
of inflammation pathways and mediator production to promote regeneration of the periodontal organ (bone,
cementum, and periodontal ligament) by directing stem cell phenotype, proliferation, and differentiation. In this
supplement, we will use our ongoing large-animal model experiments to dissect the impact of dietary
supplements on the SPM pathways leading to periodontal ligament stem cell control of regeneration. In the
miniature pig periodontal regeneration experiments, we will determine whether dietary supplementation with
EPA/DHA or concentrated HEPE/HDHA resolvin precursors enhances periodontal regeneration alone or in
combination with transplanted, ex vivo expanded miniature pig stem cells and determine the impact of dietary
supplementation with EPA/DHA or concentrated HEPE/HDHA resolvin precursors on systemic (blood) and
local tissue levels of pro-inflammatory and proresolving lipid mediators. These experiments are critical and
focused to determine the potential of dietary supplementation with n-3 PUFAs for periodontal regeneration.

Public health relevance
Project Narrative In this proposal, we plan to evaluate the impact of omega-3 polyunsaturated fatty acid (n-3 PUFA) supplements in the diet on the outcome of periodontal regeneration procedures. n-3 PUFA are known precursor of specialized proresolving mediators that have a positive impact on wound healing. We will address the question of whether dietary supplements with n-3 PUFA will result in sufficient production of SPMs to enhance outcomes in periodontal regeneration procedures in the miniature pig model of periodontal disease.